The Impact of Telestroke on Patterns of Care and Long-Term Outcomes

PROJECT SUMMARY
In select patients, early reperfusion for acute stroke saves lives and reduces disability. The question is how to
ensure that reperfusion is provided to all eligible patients. Larger hospitals typically have on-call stroke teams
that quickly assess patients with suspected stroke and determine eligibility. Unfortunately, most smaller, rural
hospitals do not have this expertise readily at hand and therefore stroke patients seen at these hospitals may
not receive these critical interventions and optimal care.
Telestroke is a potential solution. In telestroke a stroke expert who is physically far away uses technology and
videoconferencing to help evaluate the patient. Availability of telestroke in emergency departments and
hospitals is increasing across the nation. The hope is that telestroke will increase rates of reperfusion, decrease
disability and mortality, and lead to regionalization of stroke care - most patients receive care near their home
while the critically ill are efficiently transferred to specialized centers. There is limited quantitative data on the
impact of telestroke on these outcomes. In this proposed mixed-methods study we use national data from
approximately 50 million adults where we match stroke patients at 767 hospitals with telestroke to similar
patients at similar hospitals without telestroke to quantify telestroke's larger impact on patterns of care (Aim 1)
as well as reperfusion, mortality, and longer-term disability (Aim 2). We complement this with qualitative
analyses on the impact of telestroke from the perspective of front-line providers and barriers and facilitators to
effective use (Aim 3). The proposed study will be the largest and most comprehensive study on telestroke to
date. Our hope is that the findings will inform more evidence-based policy and clinical decisions on telestroke
and where patients with acute stroke receive care.

Public health relevance
PROJECT NARRATIVE Many patients with a stroke, in particular those in rural communities, receive care at an emergency department that does not have a stroke expert and therefore they may not receive life-saving reperfusion. Telestroke is one potential solution; with telestroke a stroke expert who is physically far away guides a local physician through the decision-making process via videoconference. In this project, our goal is to understand the impact of telestroke on where patients get care, likelihood of dying, disability, and the experience of front-line physicians and nurses.